Integration of Sotair with Capnography for Standardizing Manual Ventilation Technique and Improving Patient Outcomes

Abstract
SafeBVM is transforming emergency ventilation through our innovative Sotair device, addressing the widespread
risks of improper manual ventilation. Manual ventilation remains a gold standard of emergency and critical care,
yet it is often delivered incorrectly, up to 81% of the time in emergency settings. Unsafe manual ventilation leads
to severe complications such as gastric insufflation, aspiration pneumonia, risk of acute lung injury (ALI) and
acute respiratory distress syndrome (ARDS), which have hefty treatment costs ranging from $36,000 to $140,000
per patient. These preventable outcomes highlight the critical need for a device that ensures safe and guideline-
compliant manual ventilation. The Sotair addresses these challenges through a flow-blocking and pressure-
control mechanism which automatically restricts unsafe flow rates exceeding 55 L/min. It also provides real-time
audiovisual feedback, guiding providers to adjust their technique for safe and effective ventilation. At just 14
grams, Sotair is lightweight, compatible with all commercially available bag-valve masks and airway devices,
and requires no external power source. Its integration into emergency workflows will facilitate personalized
ventilation while significantly reducing complications. Based on both studies in the literature and discussions with
EMS personnel and key opinion leaders (KOLs), further improvements in ventilation could be gained by
integrating a capnography sensor into the Sotair, enabling real-time end-tidal CO₂ (EtCO₂) monitoring as well as
ventilation control while also reducing workflow complexity and minimizing dead space. By combining ventilation
control with real-time EtCO₂ monitoring, this novel device will not only simplify emergency airway management
but also result in further improvements in patient outcomes, reducing life-threatening complications associated
with improper manual ventilation. The specific aims of this project are as follows: Aim 1) Design, Engineering,
and Prototyping of the Sotair + Capnography Integrated Device. Aim 2) Testing and Preparation of Filing for
Regulatory Approval. These efforts will result in the preparation of a comprehensive submission for FDA
clearance and will pave the way for successful commercialization of the Sotair device. This innovation positions
Sotair as the new gold standard for manual ventilation, enabling safer and more effective care even in resource-
limited emergency environments.

Public health relevance
Narrative Development of a Sotair device with real-time capnography monitoring addresses the critical issue of unsafe manual ventilation, which is a leading cause of preventable complications in emergency care. The device will optimize ventilation practices and reduce complications such as aspiration and gastric insufflation, saving thousands of lives annually. By improving the standard of care for manual ventilation, this project will reduce healthcare costs, as well as enhance the quality of emergency care, which in turn will improve overall public health.